Versatile, exponentially scalable methods for single cell molecular profiling

ABSTRACT
Within the past decade, single cell biology has exploded, and researchers now routinely characterize the
molecular contents of individual cells obtained from both in vitro and in vivo contexts. However, the most widely
used methods remain limited in critical ways. Through the first cycle of this award, we substantially broadened
the scope and improved the performance of an exponentially scalable paradigm called single cell combinatorial
indexing (“sci-*”). This included the development of new sci-* methods for nuclear oligo hashing, chemical
transcriptomics, spatial transcriptomics and nascent transcriptomics, as well as markedly improved versions of
sci-RNA-seq and sci-ATAC-seq. In parallel, we laid the foundation for a new generation of molecular recorders
based on prime editing, termed DNA Typewriter and ENGRAM. In this renewal application, we propose to further
advance sci-* and related methods with the goal of enabling the massively scalable perturbation and readout of
multicellular model systems. Specifically, we propose to develop methods for: (1) “targeted molecular queries”
of individual cells in sci-* experiments (payload, location, effect) that can be correlated with their genome-wide
molecular states (Aim 1); (2) spatially-resolved chromatin accessibility and gene expression profiling with
minimal or no optics, over a range of physical scales (Aim 2); and (3) molecular recording of both cell lineage
and cell state to the genome, and efficient recovery of recorded histories via single cell profiling (Aim 3). Finally,
in addition to continuing our practice of open and early sharing of protocols, data and software, we will proactively
simplify and standardize newly developed methods and software for a broad range of users, in order to
accelerate their adoption by the community (Aim 4). Of note, we have structured our plans to initially demonstrate
QHZO\ GHYHORSHG PHWKRGV LQ D FRPPRQ VHW RI PRGHO V\VWHPVʊVSHFLILFDOO\ PDPPDOLDQ HPEU\RLG ERGLHV in
vitro) and zebrafish organogenesis (in vivo). By facilitating the recovery of information pertaining to perturbation,
spatial coordinates and lineage/state history in conjunction with a paradigm that now routinely scales to millions
of single cells, we aim to lay the technical foundation for multiplex perturbational experiments of multicellular
models of human biology at an unprecedented scale. Looking even further ahead, we envision that the
systematic perturbation and single cell profiling of such complex model systems will powerfully inform
quantitative models of gene regulation.

Public health relevance
NARRATIVE A human body is composed of trillions of cells. Within the past decade, single cell biology has exploded, and researchers now routinely characterize the molecular contents of individual cells obtained from human and animal tissues. However, the most widely used methods remain limited in critical ways. The open-source technologies and protocols developed and proactively disseminated by this project will advance the field's ability to scalably measure and record biology at single cell resolution, and especially so in the context of genetic and chemical perturbations of key model systems.